DNA Damage Repair Pathways Play a Critical Role in Myeloid Differentiation

PROJECT SUMMARY
Differentiation of myeloid progenitor cells produces a wide variety of downstream effector cells that are
integral components of the innate immune system. During hematopoiesis, monocytes are produced as
surveillance units, waiting to receive signals from cytokines identifying regions of inflammation or infection.
Induction of differentiation may produce dendritic cells or macrophages, dependent on the signals received,
and inflammatory conditions are associated with the release of DNA damaging agents that could potentially
impact the function of immune cells. But the mechanisms involved in protecting the differentiated effector
cells from DNA damage is relatively under-investigated, particularly for dendritic cells. Therefore, in this
proposal we investigate how DNA damage and repair affect the differentiation and activation of dendritic
cells. Our preliminary data indicate a major deficiency in the nucleotide excision repair (NER) pathway in
dendritic cells, whereas other pathways, including non-homologous end joining and base excision repair
remain proficient. Since these pathways specialize in the repair of different types of DNA damage, these
data suggest that dendritic cells may be more sensitive to some DNA damaging agents than others. The
goals of this proposal are to determine the role of DNA repair during the differentiation and activation of
dendritic cells and to determine the effect of dysregulation of the NER pathway on the ability to mount an
inflammatory response in the lung. I hypothesize that DNA repair plays a critical role in the differentiation
and the function of dendritic cells and that dysregulation of DNA repair diminishes the ability of dendritic cells
to activate T cells. In order to study this, I will first determine the effect of DNA damage on the differentiation
and activation of dendritic cells. By first isolating human monocytes and then challenging them with a panel
of DNA damaging agents during differentiation, I will determine how specific types of DNA damage affect the
differentiation of dendritic cells and their ability of to activate T cells in vitro. To determine how inefficient
DNA repair affects dendritic cell differentiation and function in vivo, I will investigate the ability of mice
deficient in the NER gene, XPC, to induce an inflammatory response after exposure to the immunogenic
agent poly(I:C). Analysis of cytokines and cell infiltrates into the bronchoalveolar lavage fluid and intact lung
tissue will be utilized in order to determine the change in dendritic cell and T cell activation compared to WT
controls. Completion of this project will yield new insights into the roles of DNA damage and repair in
dendritic cell differentiation and function, and will provide a foundation for understanding and possibly
controlling immune responses in patients, particularly under conditions that promote DNA damage including
cancer therapy, inflammation, and inhaled toxicants.

Public health relevance
PROJECT NARRATIVE Dendritic cells form a bridge between the adaptive immune system and the innate immune system, which acts as the body’s first line of defense against antigenic agents. My preliminary data and the work of others suggest that proper immune function is highly dependent on the maintenance of genomic integrity in innate immune cells, but the mechanistic basis for this and the role of genome integrity in dendritic cells in particular are not understood. Therefore, this project will analyze how DNA damage and alterations in the DNA repair capacity affect the differentiation and activation of dendritic cells.